Universal Precision Tool for Single Cell Capture, Conditioning, and Dispensing

DESCRIPTION (provided by applicant): Single cell biology has offered a new path to obtain biological insight that has been masked by the ensemble average from a large cell population. Studying biology at the single-cell level will not only enhance our understanding of the complicated biological mechanisms but also help produce new therapy and drugs to cure human diseases. To support single cell analysis, new tools of extraordinary precision, flexibility, and capability have to be developed. Although microfluidic device has been demonstrated as a highly promising platform for investigating single cells, one serious limit of today's microfluidic single-cell device is that cells in microfluidic environment is very different from cells in standad culture environment and even more different from cells in physiological environment. We propose to develop a universal microfluidic single-cell dispensing and conditioning device to addresses this important limitation. The device has an innovative architecture that integrates different functions, including single cell detection, capturing, conditioning, and release, on a microfluidic platform. The proposed device will operate in a close-loop fashion, requiring no user intervention once the user application is specified, due to the field-programmable-gate-array (FPGA) control and coordination of all the functions together. Besides these unique features, the proposed device can be manufactured at very low cost, fully automated, compatible with industrial standards, and expanded into array format for ultrahigh throughput. The proposed device is intended to become a tool that will be widely used on a daily base by researchers performing fundamental and clinical research benefiting from single cell studies. Since single-cell biology prevails in many areas of biology and medicine, the proposed device is anticipated to satisfy a major need in biomedicine with increasing demands in the future. If developed successfully, the device will facilitate and accelerate discoveries in cancer and stem cell research, new cell therapy, drug screening and testing, infectious and genetic diseases, cell-cell interactions, and cell signaling. The device will also become an invaluable tool for the development of medical devices and assays dealing with rare cell populations such as assays for circulating tumor cells (CTCs), cancer stem cells and personalized medicine.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose to develop a universal tool to facilitate and enhance single cell research. Employing an innovative device architecture that integrates the functions of single cell detection, capture, conditioning, and release, the device not only offers the much needed precision and flexibility for single cell research but also keeps single cells in the environments closest to the physiological environment. The proposed project aims at demonstrating the concept and viability of the technology with functional device prototypes for single cell research.